Effects of germline GATA3 variants on ALL somatic genomics and prognosis in multi-ethnic populations

Abstract
Acute lymphoblastic leukemia (ALL) is the most common pediatric cancer and the leading cause of disease-related
death among children in the US. Taking a genome-wide association study (GWAS) approach, we and others have
identified 17 genomic loci associated with susceptibility to ALL in children. In particular, our group reported germline
genetic variants in the GATA3 gene that strongly influence the risk of developing Ph-like ALL, a novel and high-risk
subtype of this pediatric cancer (Nat Genet 45:1494). Additionally, and importantly, GATA3 variants are also related
to poor response to ALL therapy, high relapse rate, and are over-represented in Hispanic children, who face inferior
survival relative to non-Hispanic whites. The potential prognostic value of GATA3 distinguishes this gene from the
majority of ALL susceptibility genes identified thus far and points to the possibility of incorporating germline
genetic factors into ALL risk stratification to further individualize leukemia therapy. However, a number of
knowledge gaps exist: 1) we have yet to comprehensively examine ALL risk variants in GATA3 beyond the index
SNP in the original GWAS; 2) the association of GATA3 variants with different subtypes within Ph-like ALL is
incompletely understood, and 3) there is no study to compare germline GATA3 variants, somatic genomic
features, and clinical variables for their relative and independent prognostic impacts in the context of
contemporary ALL treatment regimens. Therefore, we hypothesize that germline GATA3 variants are
independent prognostic factors in pediatric ALL and can be used to further improve risk classification, particularly
among Hispanics. Collaborating with the Children's Oncology Group (COG), we will first comprehensively examine
GATA3 germline polymorphisms and test their association with ALL genomic abnormalities in two national ALL
frontline trials (AALL0331 and AALL1131 trials, N=4,062). Focusing on these two large clinical trials, we will evaluate
effects of GATA3 variants on early treatment response, ALL relapse, and event-free survival, in conjunction with
somatic genomic factors and clinical presenting features. Lastly, we will explore the contribution of GATA3 variants
to inferior ALL outcome in Hispanics, utilizing the national epidemiologic cohort for pediatric leukemia disparities
research, namely the REDIAL consortium (N=1,000) by integrating clinical, genetic, and socioeconomic variables.
Our long-term goal is to integrate germline genetic factors such as GATA3 variants into ALL risk stratification to
improve outcome, which represents a significant shift from the current paradigm that relies entirely on somatic
genomics and clinical features. Here, we comprehensively leverage the NIH's investment in national pediatric
ALL trials and also state-of-the-art genomic datasets related to ALL, thus making this project feasible within this
time frame and also cost-effective.

Public health relevance
Project narrative We and others recently identified germline genetic variants in the GATA3 gene associated with high-risk subtypes of pediatric acute lymphoblastic leukemia (ALL) with potential prognostic impact in children with this cancer. Building upon these findings, we propose to comprehensively evaluate germline polymorphisms at the GATA3 locus for their association with somatic genomic features of ALL and their effects on treatment outcomes in the context of national ALL frontline trials, to refine ALL risk classification schema in children. Importantly, because GATA3 variants are over-represented in Hispanics, we hypothesize they are also related to lower survival rate in Hispanic children with ALL and therefore will examine GATA3 variants for their contribution to racial disparities in this cancer.